IMMUNOGENICITY TRIAL OF UBI KIV LIPOPEPTIDE VACCINE COMPONENT P3C541B

To evaluate an HIV synthetic lipopeptide candidate vaccine component, at two dose levels, administered subcutaneously (s.c.) in a randomized, double-blinded, placebo-controlled study.